Community Engagement Core

PROJECT SUMMARY: COMMUNITY ENAGEMENT CORE
The Center’s Community Engagement Core (CEC) will use a multifaceted approach to engage
stakeholders to change behavior, inform management decisions, and identify policies that could
be proposed to address the effects of cyanobacterial Harmful Algal Blooms (cHABs) on human
health in the Great Lakes region. The CEC will (1) strengthen environmental literacy, (2)
disseminate and implement scientific research findings, and (3) both identify and address
research gaps by engaging with key and stakeholders (e.g., decision makers, agency staff,
students, local business, media personnel, watershed residents). The Center’s goal is not only to
understand cHABs risk more thoroughly, but via the CEC to (1) prevent future issues by informing
management and policy levers and (2) reducing or eliminating harm by engaging with individuals
that have increased risk of exposure to cHABs. This engagement approach will be guided by Sea
Grant leaders, who have years of experience designing and deploying informal outreach and
formal education programming that help resource managers (1) use ecosystem-based
approaches to manage land, water and living resources in coastal areas; (2) implement
sustainable economic and environmental development practices and policies; (3) implement
hazard resiliency practices to prepare for, respond to, or minimize coastal hazardous events; and
(4) develop outreach products and tools that advance environmental literacy and workforce
development. The CEC will leverage the Center’s research enterprise to recruit and train the
next-generation of OHH scientists via the numerous NSF programs, fellowship programs, and
hands-on “camp” experiences for high school students supported at members’ respective
institutions. The CEC will promote the dissemination of cHAB research to the general public and
enhance scientific writing by engaging with media partners and journalism departments at select
member institutions. CEC, working with the University of Toledo’s Environmental, Occupational,
and Community Medicine Program, will (1) facilitate community and stakeholder involvement in
clinical and translational research and (2) identify environmental factors that contribute to poor
health outcomes. Finally, the CEC will leverage established outreach relationships with the Lake
Erie Charter Boat Captains Association and the U.S. Coast Guard to engage key stakeholder
groups with findings from the Center’s cHAB research. These efforts will facilitate the translation
of scientific insights into actionable guidance, supporting behavior change and informing
management strategies and policy decisions related to harmful algal bloom risks.